Role of Wnt-Beta-catenin in liver development and metabolic zonation

ABSTRACT
The Wnt-b-catenin pathway plays key roles in liver pathophysiology especially in regulating hepatocyte
proliferation, survival, and differentiation. Our previous investigations have contributed to a better understanding
of this signaling pathway in the process of liver development, metabolic zonation (or simply zonation) and liver
repair. The current proposal is directed at improving our understanding of the role and regulation of the Wnt-b-
catenin signaling in hepatic development and zonation. Previously, we have discovered an indispensable role of
b-catenin in liver development when hepatoblast-specific b-catenin knockouts (KOs) manifested fetal lethality at
embryonic day 17 (E17) due to decreased cell proliferation and defective hepatocyte maturation. Our preliminary
data now suggests Wnts to be regulating b-catenin activation during liver development since conditional loss of
redundant Wnt co-receptors LDL related protein 5 (Lrp5) and Lrp6 from hepatoblasts led to no viable KO.
Interestingly, KO of Wntless (Wls) (required for cellular Wnt secretion) from liver endothelial cells or from
macrophages were viable despite these cre lines being active during liver development. In aim 1 we will test the
hypothesis that b-catenin control during prenatal hepatic development is Wnt-dependent. We will characterize
hepatoblast-Lrp5-6-DKO comprehensively. We will also delete Wls simultaneously from both macrophages and
endothelial cells. Our laboratory has also contributed to an understanding of the Wnt-b-catenin pathway in
regulating the process of zonation, which encompasses heterogeneous gene expression by hepatocytes based
on their location in liver lobule. We also identified Wnt2 and Wn9b expression in zone-3 endothelial cells to
activate b-catenin signaling in zone-3 hepatocytes and control gene expression. Conditional loss from
hepatocytes of b-catenin, Lrp5-6, or from endothelial cells of Wls or Wnt2-Wnt9b, exhibits loss of zone-3 genes
and gain of non-zone-3 genes in zone-3 hepatocytes. Aim 2 will test two hypotheses. First, while Wnt-b-catenin
target genes exist primarily in zone-3, there may be additional targets in zone-2 and zone-1 due to a gradually
declining Wnt2 and Wnt9b gradient. Using newly obtained zone-specific Cre lines, we will delete b-catenin from
each of the 3 zones individually and perform transcriptomic analysis on hepatocytes to identify b-catenin targets.
Our 2nd hypothesis is that due to similarity of consensus sequence of Wnt response element (WRE) and DR-1
element, zonation is regulated by competition between b-catenin-TCF4 and HNF4a to bind and activate their
target genes in different zones. We will test if presence of b-catenin drives TCF4 to bind its target genes at the
WRE and induce their transcriptional activation while binding DR-1 element on HNF4a target genes and blocking
their expression. In the absence of b-catenin, TCF4 alone serves as a transcription repressor of Wnt target genes
& allows TCF4 to be displaced by pan-zonally present nuclear HNF4a which can activate its target genes. We
will use RNA-seq, ATAC-seq and ChIP-seq on zone-specific hepatocytes with normal, absent or activated b-
catenin to show this competition. We will also address any impact of b-catenin modulation in one zone on the
adjacent zones for changes in gene expression, chromatin accessibility and promoter occupancy by HNFa,
TCF4 and b-catenin. Lastly, aim 3 will address the mechanism of constitutive baseline expression of Wnt2 and
Wnt9b in endothelial cells in zone-3 only. We posit that hypoxia signaling in endothelial cells controls the
expression of Wnt2 and Wnt9b in these cells. We will generate and characterize endothelial cell KOs of Hif1a-
Hif2a and of Aryl Hydrocarbon Receptor Nuclear Translocator for Wnt-b-catenin signaling and zonation via gene
expression, single cell spatial transcriptomics and functional studies. Overall, our studies will uncover novel
regulation of liver development and zonation which would have implications in hepatic health and disease.

Public health relevance
NARRATIVE The current study will help understand what controls b-catenin in developing livers. This study will also help unravel the mechanism of how Wnt-b-catenin signaling patterns liver zonation by activating expression of specific genes while inhibiting expression of other genes in specific zone of liver lobule. Finally, this study will investigate hypoxia to endothelial cells in specific liver zone to be driving Wnt-b-catenin signaling and zonation.